Integrated Empirical and Translational Research to Diversify the Scientific Workforce

Summary/Abstract
The rate of diversification of the scientific workforce has been extraordinarily slow despite efforts of
thousands of individuals and large financial investments from government and private agencies over the past
4+ decades. In particular, faculty diversity in biomedical and other natural sciences has not changed to any
meaningful degree. Most research to address this problem has focused early in the pipeline, on ways to
improve retention in college STEM majors, a sense of belonging in STEM fields, and entry into PhD programs.
Modest success has been achieved in entry of students from underrepresented (UR) ethnic and racial groups,
and women into biomedical PhD training. However, these changes have not led to any real improvement in UR
or gender diversity at the faculty level. Single time, cross-sectional survey studies have shed some light on this
seemingly intractable problem, but they are limited by recall bias and lack the capacity to explain the
complexity of individuals’ experiences over time. Our research combines two research streams aiming to fully
understand experiences and career intentions of biomedical scientists: 1) through a large-scale, empirical
study beginning in 2008, “The National Longitudinal Study of Young Life Scientists,” we are following the
experiences and decision-making of a diverse group of biomedical PhD students from the start of the PhD; 2)
with translational research beginning in 2011, “The Academy for Future Science Faculty,” we implemented
a randomized controlled trial of a novel group coaching model to augment uneven mentoring and address the
isolation faced by young UR scientists. Both are prospective qualitative studies using annual, in-depth, one-on-
one interviews. We have drawn on multiple social science theories for interim analyses with sub-groups of
students. The great majority have completed the PhD; for the first time, we have revealed the great fluidity of
career intentions during training. With continuing interviews, we are poised to follow them into their careers.
The combined studies are unprecedented in their scope and duration. As of January 1, 2020, we continue
to engage 289 young scientists who have begun, or are still on a path towards, an academic career. Of this
number, 116 (40%) are UR individuals and 170 (59%) are women. Analysis of interview data has provided new
insights into the complexity of career intentions during the PhD. The next 5 years of interviews will reveal how
career intentions change during postdoctoral training; factors that influence those intentions; and, for the first
time, prospective insights on what leads to achievement and success in academic careers. The diversity of the
study population will allow detailed comparison across racial/ethnic groups and gender. Our emerging model
from the data shows how elements and integration of several social science theories will explain the lower
likelihood that individuals from UR groups will choose and persist in academic careers. With inclusion of the
Academy participants, we will be able to study the long-term effects of this novel intervention and identify
features and aspects that can be translated to student support and diversity efforts.

Public health relevance
Narrative Continued progress toward solving today's complex health and scientific questions requires diverse perspectives and skills, but the ethnic and racial diversity of the U.S. scientific workforce remains remarkably low. This research will improve our understanding of how aspiring scientists from different backgrounds make decisions about, persist toward, and succeed in various science careers. This project also tests a novel group coaching approach, based on early results and well-tested social science theories, that addresses theoretical and practical reasons for stalled progress in diversifying the faculty ranks of colleges and universities.